ALBINO DELETION COMPLEX AND EARLY MOUSE DEVELOPMENT

Provide a summary of the proposed activity suitable for dissemination to the public. It should be a self-contained description of the project and should contain a statement of objectives and methods to be employed. It should be informative to other persons working in the same or related fields and insofar as possible understandable to a scientifically or technically literate lay reader. This abstract must not include any proprietary or confidential information. This section must be no longer than 30 lines of text. 2.

Public health relevance
Many human diseases are the result of incorrect interpretation of genome sequence due to abnormalities in the structure of chromatin that packages DNA in the nucleus. Studies on chromatin remodeling proteins and non-coding RNAs have demonstrated their ability to disrupt histone-DNA contacts and reposition nucleosomes. Consequently, these complexes are critical in regulating global gene expression. Genetic experiments that elucidate the biological specificity of these proteins and non-coding RNAs, along with the abnormal outcomes associated with disease states when inappropriately expressed, will be beneficial to studies related to human health.